ESTEEMED LEArning and Discovery through Engineering Research at Syracuse (LEADERS)

To maintain its position as a global leader in healthcare and medicine, the US needs to strengthen its workforce
by including greater numbers of scientists from diverse backgrounds in bioengineering and biomedicine research
careers. However, this goal is not attainable without first increasing the diversity of students in undergraduate
engineering programs, which is an acute challenge nationally. Racial and ethnic minorities, people with
disabilities, and individuals from disadvantaged backgrounds are significantly underrepresented in biomedical
engineering research. A variety of academic and non-academic factors contribute to these students’ decisions
to join an undergraduate engineering or bioengineering program. To eliminate these limiting factors, there is an
urgent need to create a diverse and inclusive ecosystem where underrepresented biomedical engineering
students feel like they belong, are expected to succeed, and are supported and mentored by an interconnected
network of faculty, staff, and peers. To achieve this goal, the ESTEEMED LEArning and Discovery through
Engineering Research at Syracuse (LEADERS) program has been developed to recruit, retain, and mentor four
cohorts of eight underrepresented students in biomedical engineering at Syracuse University who go on to join
doctoral programs and subsequently lead independent research careers in bioengineering, biomedicine, and
behavioral research. The ESTEEMED LEADERS program will shift the current paradigm of the limited number
of students from diverse backgrounds in bioengineering at Syracuse to a new ecosystem of inclusive research
excellence that promotes attaining a doctorate through a deliberate, focused, and well-resourced approach to
attracting and advancing these talented young people. We will introduce the concepts and skills needed to
achieve these aims via rich programmatic support and activities during the six-week summer bridge program.
These concepts and skills will be reinforced in the first academic year, and the students will master them by the
end of the second academic year. These goals will be accomplished through four programmatic pillars—Aim 1:
Boost students’ confidence in their academic abilities. Aim 2: Engage students in immersive research
experiences in bioengineering and biomedicine research. Aim 3: Provide focused mentoring and skill
development. Aim 4: Enhance students’ perspectives on the impact of bioengineering careers on society. These
collective experiences and authentic research training over the two years will enable students to transition into
the Renée Crown Honors Program. In Honors, students will receive more support to enable their development
of an Honors theses and their pursuit of graduate school. Thus, the program's overarching mission is to increase
the numbers of underrepresented bioengineering students who pursue the PhD or the MD/PhD, and so
contribute to the nation's need for a more diverse research workforce.

Public health relevance
Project Narrative The ESTEEMED LEADERS program will help the U.S. maintain its position as a global leader in healthcare and medicine, by educating and providing research training to cohorts of highly talented students from diverse backgrounds including those from racial and ethnic minorities, persons with disabilities, or from economically disadvantaged environments. The program will recruit, retain, and mentor four cohorts of such students in an inclusive bioengineering ecosystem; students will feel like they belong, expect to succeed, and will be supported and mentored by an interconnected network of faculty, staff, and peers. Through this new, robust platform, upon graduation students will be competitive for and motivated to pursue highly competitive doctoral programs culminating in research careers in bioengineering, biomedicine, and behavioral research.